A RANDOMIZED, DOUBLE-BLIND, PLACEBO-CONTROLLED STUDY OF INTRAVENOUS ONDANSETRON

Ondansetron has been found to be statically superior to placebo in preventing emesis in postoperative pediatric patients undergoing outpatient surgery. Side effects such as headache, dizziness and drowsiness/sedation were the most commonly reported adverse events. An attempt will be made to expand the labeling indications for the drug.